EPR Spectroscopic Studies of Membrane Proteins

Project Summary/Abstract
Overview of Research in the Lorigan Lab and 5 Year Goals
(Overview): Currently, we have limited structural information on membrane proteins. The Lorigan lab is
interested in developing new biophysical methods to probe the structural and dynamic properties of
integral membrane proteins using state-of-the-art pulsed EPR spectroscopic techniques and membrane
solubilizing polymers. The overall objective is to study membrane proteins with EPR in a lipid bilayer as
opposed to a detergent because it more closely mimics a cell membrane. Several proteins have been
shown to not function or fold up correctly in a micelle when compared to a lipid bilayer. This is
challenging because it is more difficult to express, purify, and conduct biophysical spectroscopic
experiments on membrane proteins in lipid bilayers when compared to micelle or globular systems. My
expertise in membrane protein EPR and sample preparation coupled with the powerful pulsed EPR
instrumentation (DEER and ESEEM) that can measure long range distances has attracted several
significant collaborators with important biological problems. My research lab works directly with several
researchers to dramatically improve the quality of membrane protein sample preparation to yield high
quality DEER data that leads to more accurate structural information. Please see the letters of support.
The major biological focus of the lab is on investigating the structural and dynamic properties of
integral membrane proteins in the KCNE family which is responsible for the modulation of voltage gated
potassium (Kv) channels including KCNQ1 (Q1). This channel is expressed throughout the body to
regulate physiological functions and mutations in this channel are linked to several diseases such as
Long QT syndrome and other heart diseases. Increased understanding of the molecular underpinnings
of KCNE modulation of potassium channels, specifically Q1, would help expand our understanding of
the etiology of these diseases. We will study three members of the KCNE family: KCNE1(E1),
KCNE3(E3), and KCNE4(E4). We are currently applying state-of-the-art EPR techniques to directly
probe the structural and dynamic properties of Q1, E1, E3, and E4. This information will help us better
understand Q1 regulation.
The following pertinent biological questions will be answered: Which segments of E3 and E4 are
helical in a lipid bilayer? What is the structure and topology of the KCNE3 and KCNE4 with respect to
the membrane? How does E1 bind and interact with Q1 that is required for function?
(5 Year Goals of the Lab): (1) Develop new biophysical techniques to dramatically improve
structural studies of membrane proteins, (2) Probe the structural and dynamic properties of E3, and E4,
(3) Elucidate the binding mechanism of E1 and Q1 to help us better understand the mechanism of Q1
regulation, and (4) Apply the membrane protein techniques that we develop to investigate the structure
of several biologically important integral membrane proteins (S2E Coronavirus Envelope Protein,
Canonical Holin, TRPV1, and Grp94) using pulsed EPR spectroscopy. The TRPV1 and GRP94
projects will be done via collaboration. Each lab will send us samples for pulsed EPR measurements.
Transformative biophysical techniques will be developed to study the structural and dynamic
properties of membrane proteins. These state-of-the-art pulsed EPR spectroscopic techniques will
move the field forward by dramatically increasing sensitivity and distance measurements of membrane
protein systems such as E3 and E4. Also, a new polymer-based membrane mimetic system will be
developed that will enable researchers to more easily conduct structural and functional measurements
of membrane proteins in a lipid bilayer. The size of the SMALPs can be fine-tuned by the polymer to
match the size of the membrane protein complex. The state-of-the-art pulse EPR techniques, unique
spin labels, and our powerful SMALPs membrane systems will dramatically improve our ability to study
the structure and dynamics of a wide variety of different membrane protein complexes of various sizes.

Public health relevance
Project Narrative We have limited structural information on membrane proteins and channels, but they play an important part in numerous biomedical diseases such as heart disease and cancer. New biophysical tools are urgently needed to study membrane proteins. The research discussed in this MIRA R35 application will develop new biophysical methods for studying the structural and dynamic properties of integral membrane proteins and channels. We will also apply these methods to probe the structure of several different biological systems. We will focus on investigating the structural and dynamic properties of integral membrane proteins in the KCNE family which is responsible for the modulation of voltage gated potassium (Kv) channels including KCNQ1 (Q1). This channel is expressed throughout the body to regulate physiological functions and mutations in this channel are linked to several diseases such as Long QT syndrome and other heart diseases. Increased understanding of the molecular underpinnings of KCNE modulation of potassium channels, specifically Q1, would help expand our understanding of the etiology of these diseases. We will study three members of the KCNE family: KCNE1(E1), KCNE3(E3), and KCNE4(E4). When E1 forms a complex with Q1, it causes the activation kinetics of the channel to slow, giving rise to the slow-delayed rectifier potassium channel, IKs, which is crucial to the repolarization of cardiac action potential. E3 forms a complex with Kv channels that are voltage-independent under physiological ranges. Q1/E3 channels are important for cardiac action potentials and transport of nutrients across epithelial cells. A major gap in our understanding of E3 is due to limited structural information. E4 has been shown to inhibit current in Kv channels, including Q1. Previously, the role of E4’s tetraleucine motif has been tied to its inhibitory effects and interaction with Kv channels. It is currently not understood how the tetraleucine motif drives protein-protein interactions and how this leads to changes in the structure of E4 Presently, E3 and E4 are being studied in the Lorigan lab to provide knowledge regarding structure, topology, and dynamics which can lead to better molecular level understanding as previously done with E1. Over the next five years, we will: (1) Develop new biophysical techniques to dramatically improve structural studies of membrane proteins, (2) Probe the structural and dynamic properties of E3, and E4, (3) Elucidate the binding mechanism of E1 and Q1 to help us better understand the mechanism of Q1 regulation, and (4) Apply the membrane protein techniques that we develop to investigate the structure of several biologically important integral membrane proteins (S2E Coronavirus Envelope Protein, Canonical Holin, TRPV1, and Grp94) using pulsed EPR spectroscopy. The TRPV1, and GRP94 projects will be done via collaboration. Each lab will send us samples for pulsed EPR measurements. Transformative biophysical techniques will be developed to study the structural and dynamic properties of membrane proteins. These state-of-the-art pulsed EPR spectroscopic techniques will move the field forward by dramatically increasing sensitivity and distance measurements of membrane protein systems such as E3 and E4. Also, a new polymer-based membrane mimetic system will be developed that will enable researchers to more easily conduct structural and functional measurements of membrane proteins in a lipid bilayer. The size of the SMALPs can be fine-tuned by the polymer to match the size of the membrane protein complex. The state-of-the-art pulse EPR techniques, unique spin labels, and our powerful SMALPs membrane systems will dramatically improve our ability to study the structure and dynamics of a wide variety of different membrane protein complexes of various sizes.